NIA/AA for Institute on Methods and Protocols for Advancement of Clinical Trials in ADRD (NIA/AA IMPACT-AD Course)

Project Summary
There is an urgent need for improved therapies for Alzheimer’s Disease and Related Dementias (ADRD). Critical
to the mission to develop treatments for and curb the public health impact of ADRD will be a new generation of
ADRD scientists, especially scientists with the unique training and skills necessary to design and perform clinical
trials. This training is rarely provided through the traditional course of medical or biostatistical education.
Moreover, to develop improved therapies for ADRD, multidisciplinary expertise in clinical trials will be necessary,
including medical specialists but also expertise in biostatistics, biomarkers, trial design, participant recruitment,
study organization, and trial ethics. This proposal requests support for a first-of-its-kind training program in the
essential elements of design and conduct of ADRD trials that will leverage the full infrastructure and expertise of
the Alzheimer’s Clinical Trials Consortium (ACTC) and be conducted annually to enable a diverse range of
clinicians, scientists and researchers to receive modern and robust training on ADRD clinical trials.

Public health relevance
Project Narrative/Relevance to public health statement The NIA/AA for Institute on Methods and Protocols for Advancement of Clinical Trials in ADRD (NIA/AA IMPACT-AD Course) is a 4.5-day multidisciplinary in-person clinical trial training course providing focused instruction on the design, conduct and analysis of ADRD clinical trials, ranging from mechanistic studies to large, community-based interventions. Multidisciplinary training that combines traditional clinical trials education with specialized skills in biostatistics, study recruitment, study organization, neuropsychology, ethics and informatics will accelerate the establishment of a new, diverse and well-trained cadre of investigators to lead the development of therapies for ADRD, a key priority for improving public health.